Pulmonary clinical medicine: PFT lab, bronchoscopy, consultation services, and education

These clinical services support clinical research for NHLBI as well as the IRP. Individuals listed here also engage in research under the auspices of funded collaborators. These services also provide structure and training for ACGME fellows and visiting residents and students who want exposure to the clinical services of NHLBI and the clinical research.

Research projects are covered in other reports from the funded collaborators from other NHLBI Critical Care and Pulmonary Labs and other IRP entities.